University of New Mexico Cancer Center Support Grant

OVERALL COMPONENT: THE UNIVERSITY OF NEW MEXICO COMPREHENSIVE CANCER CENTER
PROJECT SUMMARY / ABSTRACT
Since achieving designation as a NCI Cancer Center in 2005 and a NCI Comprehensive Cancer Center in 2015,
the University of New Mexico Comprehensive Cancer Center (UNMCCC) and its Consortium Partner, Lovelace
Biomedical/The Lovelace Respiratory Research Institute (LRRI), have built a single transdisciplinary cancer-
focused research enterprise across its catchment area, the State of New Mexico (NM). The distinguishing
characteristics of the UNMCCC include: 1) the multiethnic, urban/rural populations that it serves - primarily
Hispanic/Latino, non-Hispanic White, American Indian, and Black - with strikingly different patterns of cancer
incidence and mortality, tremendous cancer health disparities, and profound socioeconomic vulnerabilities; 2)
deep engagement and unique research and education and training partnerships with American Indian (AI)
Nations and Hispanic (H) communities; 3) statewide cancer surveillance, screening registries, and unique tele-
mentoring infrastructures that facilitate cancer control research; and 4) a statewide clinical trials network, funded
as a Minority/Underserved NCI Community Oncology Research Program, engaging the majority of the state's
oncology providers. The UNMCCC mission is to reduce the cancer burden and overcome the tremendous cancer
health disparities of the NM catchment area through ground-breaking transdisciplinary research, translation of
discoveries to clinical and community interventions, impactful bi-directional community engagement, training of
a more diverse cancer workforce, and delivery of exceptional cancer care. With extensive strategic planning and
evaluation, the UNMCCC significantly restructured and enhanced its Leadership, 3 Research Programs, 9
Shared Resources, and clinical research infrastructure to assure the Center's continued growth. Since 2015, 33
new Members were recruited and 23 Endowed Positions created. The Center's 102 Members are clustered into
3 interdisciplinary, highly translational Research Programs (Cancer Control & Population Sciences, Cellular &
Molecular Oncology, and Cancer Therapeutics), supported by $36,196,038 in annual direct cancer-relevant
funding, of which $27,542,340 is peer-reviewed and $8,245,544 is NCI. With $3,009,657 in additional NCI
contracts and supplements, total annual NCI funding to the Center is $11,255,201. UNMCCC research is highly
interactive and impactful (with collaborative publications ranging from 34-60% in its Research Programs, 16% of
930 publications in high impact journals, 136 patents filed, and 10 new companies launched). Four UNMCCC
discoveries were translated to early phase trials, one of which is now a national NCTN NRG trial. Of 1361
accruals in 2019, 40% of interventional treatment accruals were racial/ethnic minorities (29% H; 6% AI), as were
55% of interventional non-treatment accruals (33% H; 12% AI). Among 530 trainees, 72% were minority/diverse
scholars. With the awarding of 27 collaborative grants (including a NCI Participant Engagement-Cancer Genome
Sequencing Research Center and 3 focused on environmental exposure and cancer causation, all engaging
Tribal Nations), the UNMCCC will continue to have a profound impact on its catchment area and the nation.

Public health relevance
OVERALL COMPONENT: THE UNIVERSITY OF NEW MEXICO COMPREHENSIVE CANCER CENTER PROJECT NARRATIVE The NCI-Designated University of New Mexico Comprehensive Cancer Center leads impactful cancer research, cancer care delivery, cancer education and training, and community-based cancer prevention and control efforts across the New Mexico catchment area, in partnership with its Consortium Partner (Lovelace Biomedical/The Lovelace Respiratory Research Institute), Tribal Nations, and community health systems statewide. The Center's overall mission is to reduce the cancer burden and overcome the tremendous cancer health disparities of the New Mexico catchment area and the nation through ground-breaking transdisciplinary research, translation of discoveries to clinical and community interventions, impactful bi-directional community engagement, training of a more diverse cancer workforce, and the delivery of exceptional cancer care.